Using Markers to Improve Pancreatic Cancer Screening

Most patients with pancreatic cancer present with advanced incurable disease, but patients
diagnosed with Stage I pancreatic cancer have a much better outcome. The early detection of
pancreatic cancer requires simple and effective pancreatic screening tests that can be applied
to high risk populations. The Cancer of the Pancreas Screening (CAPS) study currently follows
a familial/genetic “high-risk” cohort of ~1000 patients undergo regular pancreatic surveillance.
Recent results from the CAPS program indicate that pancreatic cancers detected during
pancreatic surveillance are down-staged; 40% of those who maintained annual surveillance had
a Stage I pancreatic cancer. These results indicate that early detection can improve overall
outcome of patients with pancreatic cancer. Circulating tumor marker tests are not currently
used for pancreas surveillance. Genetic factors are known to influence tumor marker levels, but
gene tests have not been evaluated to determine if they could improve the accuracy of tumor
markers. Recent studies from the PI's lab indicate that the normal reference ranges of
commonly used tumor markers (CA19-9, CA-125 and CEA) are better defined by an individual's
tumor marker genotype. A tumor marker genotype test can improve the diagnostic sensitivity of
tumor markers at 99% specificity compared to conventional diagnostic cut-offs. We propose to
establish genetically-defined normal reference ranges for tumor marker levels and evaluate their
diagnostic accuracy in a prospective clinical trial of patients undergoing pancreatic imaging
surveillance through our CAPS program. The addition of annual blood tests to pancreatic
surveillance is expected to improve the detection of early-stage pancreatic cancer.

Public health relevance
 Project Narrative Pancreatic cancer is the deadliest of the common cancers and one of commonest causes of cancer death. Detecting pancreatic cancer at an early stage greatly improves survival from pancreatic cancer. We propose to validate the diagnostic accuracy of a tumor marker gene blood test for pancreatic cancer early detection and use this test in a clinical trial to improve the early detection of pancreatic cancer for patients with an increased susceptibility to pancreatic cancer undergoing pancreatic screening.